Increasing and Improving Conformance with Retail Food Programs in the East Metro Health District

ABSTRACT Participation in the Voluntary National Retail Food Regulatory Program Standards (Program Standards) serves to develop and enhance an effective food safety systems in a unified way that reduces or eliminates foodborne illness or injury. The mission of the East Metro Health District (EMHD) is protect and improve the health of our community by monitoring and preventing disease; promoting health and well-being; and preparing for disasters. Therefore, EMHD enrolled in the Program Standards as method to achieve its mission. Participation in this cooperative agreement would be most supportive of EMHD’s mission. The specific aims are to: 1. Achieve greater conformance with the Voluntary National Retail Food Regulatory Program Standards (Program Standards) by achieving the remaining two Standards. This will be done by: a. Enhancing existing foodborne illness and defense preparedness and response protocols managed by the collaborative efforts of EMHD’s Environmental Health and Epidemiology Departments (Standard 5). b. Creating and maintaining documentation and tools to monitor staffing, equipment, and budgets to achieve and execute an effective and efficient risked-based food service program. (Standard 8). 2. Develop strategies for improving upon Standards that have been achieved that can be shared and duplicated by other agencies such as: a. Improvement in the new Food Safety Inspection Officer (FSIO) Training as gaps have been highlighted over the past year (Standard 2). b. Creating a more uniform inspection program through continuous education (Standard 4). EMHD will develop a new inspectional software system to better conform to the Program Standards that allows for more effective and efficient inspections and data analysis. This new data system serves as an innovative method to maintain and develop the food safety program as required by advancements and growth in food production and food service in our communities.

Public health relevance
PROJECT NARRATIVE This cooperative agreement serves to develop and enhance the infrastructure of the East Metro Health District (EMHD) food safety program. Participation in the Program Standards serves to contribute to a uniform and effective national food safety system that can be achieved through data sharing with other jurisdictions. Ultimately, foodborne risk factors will be identified, interventions developed to address the remediation, and trend analysis to assess the program to determine effective means to protect the health of the public.